Mechanism by which ketogenic diet uncouples tumor growth and overall survival

The overarching goal of this proposal is to add to the understanding of the complex interaction between the
tumor and the host organism to facilitate new therapeutic approaches in cancer medicine. Specifically, we aim
to establish the mechanistic explanation for the observation in two IL-6 associated murine models of cancer
cachexia that KD delays tumor growth but accelerates cancer cachexia and shortens survival. We discovered
that this uncoupling may be a consequence of the biochemical interaction of two simultaneously occurring
NADPH-dependent pathways. Within the tumor, increased production of LPPs and, consequently, saturation of
the glutathione system leads to ferroptotic death of cancer cells. Systemically, redox imbalance and NADPH
depletion impairs the biosynthesis of corticosterone, the main regulator of metabolic stress, in the adrenal
glands.
The proposal seeks to build on these discoveries in three ways. First, we will determine specific
polyunsaturated fat enriched diets and ferroptosis inducing drugs, including licensed medications, that
exacerbate the anti-cancer effect. Second, after validating that glucocorticoid deficiency is a critical component
of survival reduction of the host organism, using plasma, liver, and adrenal focused assays, we will use
systematic pharmacological rescue experiments to enable a therapeutic window for KD intervention. Third, we
will track how oxidative stress induced GDF-15 elevations may conspire with IL-6 elevations to drive cachexia
associated anorexia via neuronal circuits and thereby cause the negative energy balance that accelerates
cachexia onset in KD fed mice.
The results of this research may be of interest to scientists and medical professionals. A combination of
administration of synthetic GCs may improve food intake, normalizes glucose homeostasis and utilization of
nutritional substances, delay the onset of cancer cachexia and extends survival of tumor-bearing mice fed KD,
while not counteracting the reduced tumor growth induced by the KD-induced ferroptosis. These studies will
emphasize the importance of considering the impact of cancer treatments on the host and the tumor.

Public health relevance
The proposal aims to investigate the interaction between tumors and host organisms to find new methods of treating cancer in the context of a ketogenic diet (KD), because KD induced reduction of tumor growth but shorter overall survival in two mouse models of cancer cachexia associated with interleukin-6 (IL-6). The mechanism of cancer cell ferroptosis and the host's inability to synthesize corticosterone during metabolic stress will be studied in the context of NADPH depletion secondary to KD-induced lipid peroxidation. The role of IL-6-induced anorexia and growth differentiation factor-15 (GDF-15)-induced anorexia as contributors to cachexia will also be examined, with the latter being elevated by oxidative stress in a KD.